Equitable and accessible wearable device for continuous calculation of blood loss for postpartum hemorrhage

PROJECT SUMMARY
Postpartum hemorrhage (PPH), defined as the loss of 1 L of blood or more within 24 hours after birth, is the
leading cause of maternal mortality worldwide. In the US, there are disturbing racial disparities, with black
mothers having a 3X increase in PPH-related death. Importantly, PPH is the most preventable cause of maternal
mortality, and the leading factors causing preventable PPH are delays in diagnosis and treatment. Thus, there
is an urgent need for an early, accurate, and equitable PPH detection system that can facilitate prompt treatment
to prevent PPH-related morbidity and mortality. During hemorrhage, several physiologic compensation
mechanisms occur to help stabilize the patient, delaying the time until global vascular indicators such as blood
pressure and heart rate are affected. These vital signs, as well as the visual estimate or quantitative
measurement of blood loss, are the current methods used to detect PPH, but provide delayed measures of PPH.
Additionally, vital signs can be affected by medications or intravenous fluid administration, making the
interpretation of vital signs difficult. Non-invasive and continuous monitoring of cardiovascular parameters would
enable rapid determination of blood loss, even in the presence of strong compensation or medical intervention,
to reduce morbidity and mortality caused by PPH. Light-based technologies are well suited to noninvasively
measure blood flow and blood content, which can provide accurate estimates of cardiovascular parameters.
However, light-based tools can be biased to skin pigmentation due to melanin absorption and must be carefully
designed and tested to ensure they are not contributing to racial disparities. The study team has specifically
designed novel light-based sensors to minimize potential skin pigmentation bias and capture important
cardiovascular parameters. Preliminary experiments have demonstrated strong correlations between the
wearable sensor data and hemorrhage severity. This proposal will use a novel bicolor swine hemorrhage model
to test the wearable sensor performance on swine with differently pigmented forelegs to isolate skin pigmentation
as a potential source of bias. The sensor will also be tested in a diverse group of human subjects undergoing
blood loss to assess wearable sensor accuracy in a wide range of skin tones. If successful, the wearable sensor
will provide a continuous and accurate estimation of blood loss, facilitating early warning for improved PPH
management and patient outcomes.

Public health relevance
PROJECT NARRATIVE Postpartum hemorrhage, the loss of one liter of blood or more within 24 hours after birth, is the global leading cause of maternal death despite being largely preventable with early diagnosis and treatment. Early, objective detection is key to successful treatment at early stages of hemorrhage when simple and accessible treatments are most effective. The goal of this proposal is to develop a wearable light-based device that accurately detects blood loss in diverse subjects and in the presence of potential confounding factors, thereby facilitating improved maternal health outcomes with early treatment.